Admin-Core

MISSISSIPPI INBRE
ADMINISTRATIVE CORE
Project Summary/Abstract
The mission of the Mississippi INBRE (MS INBRE) network is to enhance the state's biomedical research
infrastructure. The role of the Administrative Core (AC) is to provide leadership and organizational support for
the network and coordinate the activities of all cores to ensure the program's three main goals are
accomplished: 1) enhance the biomedical research capacity in Mississippi; 2) develop a skilled and diverse
workforce in biomedical research and health-related careers; and 3) engage underserved communities and
address health disparities. As the only statewide network that engages all academic institutions in the state, it
is critical that the AC efficiently coordinates network activities to ensure maximum impact. The MS INBRE
program cores have been designed to work synergistically to accomplish the overall mission of enhancing the
biomedical research and workforce capacity of the state of Mississippi. The AC provides logistical support and
oversight for all network cores. All network policies and procedures are developed with active participation of
the Steering Committee and the External Advisory Committee. The AC has also developed internal and
external evaluation procedures to develop priorities and ensure accomplishment of the Mississippi mission. We
have developed the following aims to efficiently carry out the goals of MS INBRE: 1) Provide leadership and
administrative support for all MS INBRE activities; 2) Development of biomedical research programs at PUIs;
3) Provide support for investigators to facilitate research; 4) Sustainability and support of core facilities; 5)
Recruiting students into biomedical research and health-related careers; 6) Broadening participation of women
and African-Americans in biomedical research and health-related careers; 7) Promote networking between
PUIs and research universities; and 8) Coordinate formative and summative evaluations of all cores and the
overall program.